Learning-induced synaptic plasticity in corticospinal output neurons of motor cortex

PROJECT SUMMARY
Learning is a fundamental process in the brain that enables flexible action—output can be adapted to develop
novel behaviors or modify existing ones. This adaptation is necessary to survive in an ever-changing, dynamic
environment. The process of learning is thought to be mediated by changes in circuit activity that are driven by
experience-dependent modifications at relevant synaptic connections. However, the mechanisms by which
learning-induced changes arise at the synaptic and circuit level remain unclear. In order to understand how
neural activity is modified with experience in order to shape behavior, one must be able to measure each of
these components over the process of learning. This type of measurement has yet to be performed due to
technical limitations for measuring these features simultaneously. The research proposed here will use cutting-
edge imaging methods combined with newly developed genetically-encoded sensors for monitoring neural
activity to monitor changes in the brain during learning of a skilled motor task. Specifically, Aim 1 of this project
will simultaneously measure synaptic and spiking activity in corticospinal projection neurons in primary motor
cortex. These neurons project directly to spinal cord circuits that control muscle activation; thus, understanding
the role of synaptic plasticity at this node in the movement pathway can directly link activity at multiple levels,
ranging from synaptic activity to behavioral output. Aim 2 of this project will develop a new behavioral task to
specifically test the hypothesis that the function of plasticity in corticospinal neurons is primarily to improve the
precision of during dexterous movements. Population activity measured over many days of training on this task
will be used to determine how different movement patterns are represented in these neurons over the course of
learning. Altogether, these experiments will provide deeper mechanistic understanding of the processes involved
in transforming neural activity during learning. Additionally, the insights from the proposed study have broader
implications for understanding the brain during natural behavior, since motor learning is required to perform many
ethological behaviors (e.g. hunting, foraging, escaping from predators), as well as disease, since deficits in motor
learning present as primary or secondary symptoms in many neurological diseases. Lastly, the findings here will
have high relevance to understanding capacity for plasticity in the corticospinal circuit to alter motor output, which
can inspire new opportunities for the development of therapeutic treatments for patients with spinal cord injuries.

Public health relevance
PROJECT NARRATIVE Corticospinal neurons serve as the output of motor cortex and coordinate muscle activation during voluntary movements. Using advanced imaging techniques in behaving animals, this proposal aims to address how synaptic plasticity in these output neurons can modify spike output in order to drive learned behaviors, thus revealing how the brain can be dynamically altered during motor learning. Findings generated from this proposal will elucidate a specific function for synaptic plasticity at the corticospinal node in the motor pathway, which is highly relevant in the context of spinal cord injury, amyotrophic lateral sclerosis, and other neurological diseases that affect learning and/or movement.